A Multifactorial Approach to Evaluating Disparities in Outcomes after Major Surgery in Disadvantaged Older Persons

ABSTRACT

Major surgery is a common event in the lives of community-living older persons, with a 5-year cumulative inci-dence of 13.8%, representing nearly 5 million persons aged 65+ y in the US. This value will increase substan-tially in the coming years based on the projected doubling of this age group to 98 million by 2060. As our society ages, it is also becoming increasingly diverse, with growing proportions of persons from disadvantaged groups, defined on the basis of individual-level and social contextual factors. Yet, despite the public health imperative, disparities in outcomes after major surgery in disadvantaged older persons are poorly understood. Prior re-search has generally relied on large administrative datasets and, hence, has usually been restricted to disadvan-taged populations defined only by individual-level demographic characteristics, a small number of short-term outcomes, and a limited set of explanatory variables. To address current gaps in knowledge, and build the evi-dence for action, a more robust approach is needed that focuses on multiple disadvantaged populations of older persons, emphasizes the importance of social contextual factors in defining the scope and complexity of disad-vantage, includes a larger array of geriatric-specific outcomes that are clinically meaningful, evaluates a com-prehensive set of explanatory variables that include modifiable patient-centered variables, and assesses the use of post-surgical palliative treatments such as hospice. The overarching objective of this proposal is to identify and elucidate sources of potential disparities in outcomes after major surgery in disadvantaged older popula-tions, defined on the basis of individual-level and social contextual factors. Building on our prior work, we will use high-quality data from the National Health and Aging and Trends Study (NHATS), an ongoing nationally representative longitudinal study that includes 7,600+ community-living persons aged 65+ y, comprehensive annual assessments with patient-centered phenotypic data that are not available in administrative datasets, co-hort replenishment at 5-year intervals, and linkages to Medicare and geographic data. This unique resource will permit a series of innovative longitudinal analyses at the patient level that will complement systems-based re-search on the quality of surgical care. We will rigorously test three distinct but related hypotheses: (1) disparities after major surgery in older persons will be observed consistently for multiple outcomes across multiple disad-vantaged populations; (2) for each disadvantaged population, these disparities in outcomes will be largely at-tributable to a set of patient-centered variables, including several that are potentially modifiable; and (3) similar disparities will be observed in the use of hospice but will not be as easily explained. By taking a comprehensive, multifactorial, and multilevel approach that emphasizes the importance of social contextual factors, the pro-posed research will build the evidence that is essential to understanding the mechanisms of potential disparities in outcomes after major surgery. These actionable results will inform novel interventions, collaborations, and policies designed to improve these outcomes in disadvantaged older persons.

Public health relevance
Public Health Relevance Identifying and elucidating sources of potential disparities in outcomes after major surgery in older Americans is needed to ensure that all persons aged 65 years or older receive high-quality care before, during, and after geriatric surgery, regardless of socioeconomic status or geographic location. By taking a comprehensive, multifactorial, and multilevel approach that emphasizes the importance of social contextual factors, the proposed research will build the evidence that is essential to understanding the sources and mechanisms of potential disparities in outcomes after major surgery. These actionable results will inform novel interventions, collaborations, and policies designed to improve these outcomes and reduce surgical inequities in older Americans.